Sleep Resource Core

Timing, content, and duration of sleep are important for multiple physiological functions, including response to
stress; body composition; neurological, cardiovascular, reproductive, and metabolic function; cognition; and
mental health. Poor sleep can be both a cause and an outcome of disease: for example, poor sleep adversely
affects health, particularly cardiometabolic health and cognitive processing, and many diseases/syndromes
disrupt sleep. These potentially bidirectional associations are particularly salient in women, in whom insomnia
prevalence rises with age, and in whom vasomotor “hot flashes” can disturb the sleep of peri- and
postmenopausal women, thereby exacerbating stress and adverse health and cognitive outcomes, including
susceptibility to dementia. A full understanding of women’s health therefore requires consideration of sleep as
potential modifying and mediating factors, especially since there are wide inter-individual variations in self-
selected sleep timing and duration. One innovation of the Brigham and Women’s Hospital/Harvard Medical
School Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes program is to
include objective sleep metrics from complementary modalities in all experimental projects, including relevant
projects funded through the Career Enhancement Core (CEC), thereby promoting interdisciplinary, collaborative,
synergistic, and translational work. Building on our experience as national resources for many other NIH-
supported research grants, the Sleep Resource Core (SRC) will collaborate with and be integrated into all
Projects and the CEC by providing sleep-related expertise, equipment, and analyses. For human experimental
studies, we will use wrist actigraphy and an online diary with questionnaires administered once or twice a day.
The SRC will purchase, calibrate, and maintain actigraphy devices, as well as download, store, and process
actigraphy data. We will manually clean and score actigraphy data and apply validated algorithms to extract
quantitative measures. The online diary includes algorithms that perform real-time error checking, thereby
increasing accuracy and decreasing data inconsistencies and data cleaning efforts. For mouse projects, the SRC
will perform the surgeries and conduct and score polysomnographic sleep recordings. These objective and
subjective sleep data will be used by each project to address their specific aims.
The SRC will also (i) train and support staff in human and animal projects (including CEC Scholars and Pilot
projects), ensuring high quality data collection; (ii) work actively with the CEC to provide data and expertise for
CEC projects and train early investigators in sleep science; (iii) assist with the interpretation and integration of
both subjective and objective sleep metrics with other exposures and covariates for all projects; and (iv)
participate in manuscript preparation and results dissemination. Sleep data and analysis tools will be made
available on the National Sleep Research Resource website. The SRC will be an integral and synergistic SCORE
component by providing resources, equipment, expertise, and sleep data to all Projects and Cores.

Public health relevance
SLEEP RESOURCE CORE NARRATIVE The Sleep Resource Core (SRC) will be integrated into this SCORE by providing equipment, analysis, sleep- related expertise, and sleep data to the two human, one animal, and relevant Career Enhancement Core projects. The scientific leadership and technical support to facilitate and integrate rigorous collection, processing, analysis, and interpretation of sleep measures, will enable the SRC to promote interdisciplinary, collaborative, synergistic, and translational work and support the scientific and career enhancement goals of this SCORE. This work will expand the scientific impact of the SCORE by including sleep as a key health measure in human and animal models of women’s health and aging, including impacts on response to stress; body composition; neurological, cardiovascular, reproductive, and metabolic function; cognition; and mental health.